Engaging and Mentoring through Biomedical Research And Career Exploration (EMBRACE)

PROJECT SUMMARY/ ABSTRACT
There is an urgent need to increase the numbers and diversity of prepared graduates joining the
biomedical workforce, through reasoned, evidence-based approaches that follow scientific practices.
Florida International University's Engaging and Mentoring through Biomedical Research And Career
Exploration (EMBRACE) project will leverage existing evidence to increase the diversity of the biomedical
research workforce through coordinated activities including, intentional career development opportunities,
authentic student research experiences, and strategic faculty professional development. FIU is an urban
Hispanic-serving research-intensive (R1) public institution with over 58,000 students, 80% of which are
from groups that are underrepresented in biomedicine. EMBRACE centers on programming that will
leverage FIU's extensive expertise in student success, diversity, equity, and inclusion and focus on
programming that transforms students' access to biomedical research experiences and career awareness
and preparation. EMBRACE aims to 1) support the development of essential biomedical career skills to
ensure students are prepared to pursue future biomedical research paths; 2) increase student access to
authentic research experiences to promote development of essential research skills; 3) provide leadership
opportunities for undergraduate students, and 4) create an informed, proactive institutional community that
collectively supports STEM students in biomedical career exploration and development. EMBRACE will
offer a novel research and career development experience sequence to increase access to research
opportunities, starting with a 1-week research exploration, continuing with increasingly immersive
experiences in a Course-based Undergraduate Research Experience (CURE) and follow-up novel Course-
based Undergraduate Research Internship Experience (CURIE), and culminating in research leadership
opportunities as undergraduate research peer mentors. Students will receive career professional
development to promote essential professional skills, awareness of biomedical research career paths, and
create opportunities for students to network with faculty, alumni, and scientists. The research curriculum
will focus on investigating infectious diseases through the lens of bioinformatics, considering the
importance to improve bioinformatics skills among the biomedical workforce and the possibility of providing
access to safely conduct infectious pathogen cutting-edge research. Additionally, the project will provide
faculty professional development to faculty teaching across the biology degree program to become
effective mentors in their large-enrollment classrooms and provide students with guidance and strategies
to support their readiness for potential biomedical careers. The integrated research and career support
activities, organized longitudinally through the biology degree program, will support a diverse group of
undergraduate students to pursue advanced studies and join the biomedical research workforce.

Public health relevance
PROJECT NARRATIVE The Engaging and Mentoring through Biomedical Research And Career Exploration (EMBRACE) project will increase the diversity of the biomedical research workforce through designing and implementing career development opportunities and research experiences for students and strategic professional development for faculty to better guide students on biomedical research careers. Students will participate in integrated research and career support activities organized longitudinally through the biology degree program, including a novel research experience sequence and career development resources, mentoring, and support. The desired outcome is to support a diverse group of undergraduate students and stimulate their interest, boost their self-efficacy, and provide strategies to pursue careers in biomedical research.